Intimate Partner Violence and HIV Prevention among Sexual Minority Men

SUMMARY/ABSTRACT
Sexual minority men (SMM) experience intimate partner violence (IPV) at alarming rates. Prior work has linked IPV
to sexual risk-taking behavior and increased risk for HIV seroconversion among SMM, but less is known about the
impact of IPV on HIV and sexually transmitted infection (STI) testing/acquisition, pre-exposure prophylaxis (PrEP)
uptake, and the persistence of PrEP use among SMM. While these findings reveal the potential for IPV to have a
strong deleterious effect on HIV prevention, experiences of IPV are so varied among SMM (e.g., frequency,
severity; steady vs. casual partnerships; mutual perpetration vs. only perpetrating or receiving violence; sexual vs.
physical vs. psychological violence) that additional research is needed to unpack the overall association between
IPV and HIV risk before effective interventions can be developed. Guided by a framework that combines the
Syndemics and Minority Stress theories, the proposed innovative observational cohort study will examine how
perpetration and/or receipt of various forms of IPV (e.g., physical, sexual, and psychological; in the context of
steady or casual intimate relationships) contribute to HIV risk and protective behaviors among HIV-negative SMM
over a 24-month timeframe in order to: 1. Examine the longitudinal associations of IPV with HIV testing, PrEP
uptake, PrEP persistence, STI diagnosis, condomless anal sex, and HIV seroconversion. 2. Determine the
structural- and individual-level and resilience and risk factors that may buffer or amplify associations between IPV
and these HIV risk and protective behaviors. 3. Identify the characteristics of SMM, their intimate partners, and the
relationship dynamics that serve to mediate the impact of IPV on HIV risk and protective behaviors. 4. Make
recommendations for interventions that interrupt the pathways between IPV and HIV risk based on quantitative data
from the cohort, and qualitative data guided by technical experts. We will assess sexual risk behavior, conduct HIV
and STI testing, and assess PrEP uptake and persistence over the 24 months of follow-up. We hypothesize that
greater frequency of IPV will be associated with history of childhood abuse, mental health problems, substance use,
sexual risk taking and lower levels of HIV testing, PrEP uptake, and PrEP persistence. We anticipate that alcohol
and substance use among participants and their partners will be highly associated with episodes of IPV (both
victimization and perpetration) and with HIV risk behavior. We also hypothesize that coping skills and social support
will mediate the effects of IPV on risk behavior, HIV testing, PrEP uptake, and PrEP persistence. The proposed
study will advance our understanding of both the risk and resiliency factors relevant to preventing and reducing IPV,
reducing IPV-associated risk behaviors, and increasing HIV protective behaviors among SMM. This research will
inform the development and adaptation of IPV, HIV, and substance abuse interventions for SMM.

Public health relevance
PROJECT NARRATIVE Sexual minority men (SMM) experience intimate partner violence (IPV) at alarming rates and prior work has linked IPV with sexual risk-taking behavior and to increased risk for HIV seroconversion among SMM, but less is known about the impact of IPV on HIV testing, pre-exposure prophylaxis (PrEP) uptake, and the persistence of PrEP use among SMM. The proposed innovative observational cohort study will examine how perpetration and/or receipt of various forms of IPV (e.g., physical, sexual, and psychological; in the context of steady or casual intimate relationships) contribute to HIV risk and protective behaviors among HIV-negative SMM over a 24-month timeframe. This research will advance our understanding of both the risk and resiliency factors relevant to preventing and reducing IPV, reducing HIV risk behaviors, and increasing HIV protective behaviors among SMM.